Bioenergetic Mechanisms of Tongue Muscle Fatigue

Abstract
Alzheimer’s disease (AD) has a primary risk factor of advanced age and accounts for 50-70% of all cases of
dementia worldwide. While cognitive decline is strongly associated with AD, so too are sarcopenia, fatigue, and
frailty. The parent grant focuses on discovering mechanisms of oromotor sarcopenia and muscle fatigue in
aging. Thus, the application of our work to AD represents a critical extension of our science. Oromotor and
swallowing impairments have been identified in patients with AD at a high prevalence and high-cost relative to
heath care utilization. Underlying mechanisms likely include sarcopenia and muscle fatigue, but this has not
been previously explored in cranial muscles. This supplement will apply techniques and approaches in current
use in our laboratory to acquiring knowledge in AD. Our global hypothesis is that AD is associated with
increases in tongue muscle sarcopenia and fatigue that contribute to deficits in oromotor function and
swallowing. We further hypothesize that tongue exercise can mitigate these deficits. We will gain insight into
mechanisms by addressing this global hypothesis in the TgF344-AD rat model of AD and conducting
physiological, morphological, bioenergetic, and behavioral assays in tongue muscles. Our tongue exercise
program is modeled after those used in current clinical practice. We have 3 specific aims: Aim 1 will test the
hypothesis that measures of tongue muscle sarcopenia are found in AD; Aim 2 will test the hypothesis that
deglutition outcomes are negatively affected by AD and are associated with measures of sarcopenia; and Aim
3 will test the hypothesis that tongue exercise leads to improvement in measures of tongue muscle sarcopenia
in a rat model of AD. Our neuromuscular paradigm is the first to evaluate these crucial issues in muscles of the
tongue in a rat model of AD. The proposed research will provide a new understanding of mechanisms that
underlie oromotor and swallowing deficits from a physiological perspective, the relationship of structural
changes to physiological function, and the effectiveness of lingual exercise as an intervention in AD.
Rehabilitation is often not provided to patients with AD due to uncertain benefit. To advance the efficacy of
services, treatments must be optimized based on preclinical methods to allow rational hypotheses for clinical
studies. This work is highly significant due to the large and increasing population of people with AD who will
benefit from treatments optimized in pre-clinical studies to address often debilitating oromotor and deglutition
impairments. In a future R01 grant application, we will propose further studies of treatment optimization for AD-
related oromotor disorders. This supplement will lay the foundation for ensuring the research of the parent
grant is translationally applicable not only to the general aging population, but also to special patient
populations with AD or high risks for AD.

Public health relevance
Narrative Alzheimer’s disease and related dementias (AD) are associated with sarcopenia and frailty, which affects the ability to control oral movements, and ability to eat and swallow safely. The proposed research examines how tongue muscle weakness and fatigue in AD may affect swallowing by examining properties of tongue muscle contraction, structure, and fatigue, and also how energy for tongue muscle contraction is altered by AD. Further, this work examines how exercise-based therapies may help with weakness and fatigue in tongue muscles.